PARTIAL SUPPORT FOR THE CORE ACTIVITIES OF THE GOVERNMENT-UNIVERSITY-INDUSTRY RESEARCH ROUNDTABLE (GUIRR)

PARTIAL SUPPORT FOR THE CORE ACTIVITIES OF THE GOVERNMENT-UNIVERSITY-INDUSTRY RESEARCH ROUNDTABLE (GUIRR).